The structural dynamics of ribosomal frameshifting and ribosome rescue

PROJECT SUMMARY
Translation of messenger RNAs (mRNAs) into proteins by the ribosome and the rest of the translation
machinery (TM) is a fundamental step in gene expression that is central to life. Because the bacterial TM is a
proven target for the development of new antibiotics and because many human diseases have been causally
linked to dysregulation of translation, the mechanisms of translation and translational control in bacteria and
eukaryotes remain under intense investigation. Over the past two decades, structural studies have revealed
the large-scale structural rearrangements the TM undergoes during protein synthesis. Unfortunately, the size,
complexity, and conformational flexibility of the TM have greatly impeded studies of these dynamics,
significantly limiting our understanding of how these dynamics contribute to the mechanisms of translation and
translational control. Nonetheless, using a combination of single-moleucle fluorescence and structural
techniques, we and others have been able to characterize the dynamics of the core steps of translation by the
bacterial TM. Despite these accomplishments, critical gaps in our understanding remain regarding whether and
how the dynamics of these core steps are modulated as part of biomedically important translational control
strategies. To fill these gaps, in the first aim of this application, we propose to use a combination of single-
molecule fluorescence, structural, and biochemical approaches to investigate how the dynamics of the
bacterial TM are modulated in order to drive ribosomal frameshifting. Frameshifting is a translational control
strategy in which the TM slips backward or forward by one or more nucleotides on the mRNA to either correct
an insertion or deletion ‘frameshift’ mutation that would otherwise result in production of an aberrant or
truncated protein or to drive the synthesis of more than one protein product from a single mRNA. These
experiments promise to reveal the still-elusive mechanism(s) that underlie frameshifting. In the second aim, we
will use analogous approaches to investigate how ribosome rescue factors modulate the dynamics of the
bacterial TM as part of the mechanisms through which they recognize and rescue ribosomes that have
become translationally compromised. These studies will provide structure-based mechanistic models of
bacterial ribosome rescue systems that can be exploited in the development of new antibiotics. In the third aim,
we will extend our combination of single-molecule fluorescence and structural techniques to a yeast translation
system, enabling us to investigate eukaryotic-specific aspects of the core steps of translation, frameshifting,
and ribosome rescue. The results of these studies will reveal the mechanisms that drive and regulate
translation in eukaryotes, providing a framework for investigating the role of translational control in human
health and disease.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT (PROJECT NARRATIVE) This proposal aims to elucidate how the process through which the ribosome, the universally distributed biological machine that synthesizes all of the proteins encoded in an organism’s genome, synthesizes proteins is controlled at a level of detail much higher than is currently available. Because the bacterial ribosome is the molecular target of over half of the small-molecule antibiotics that are in current clinical use, the results of the proposed studies are expected to identify new targets and strategies for the development of next-generation antibiotics. Similarly, because aberrant control over the process through which the human ribosome synthesizes proteins plays a causal role in several human diseases, including numerous viral infections and cancers, the results of the proposed studies are expected to inform the development of small-molecule therapeutics that can be used to treat viral infections, cancers, and other human diseases.